Refactoring Soft Coral Diterpenoid Biosynthesis

Project Summary
Soft corals (Alcyonaria) are a remarkable source of natural products (NPs) with pharmaceutically relevant
biological activity, and complex scaffolds that are unique to marine eukaryotes with no terrestrial sources of
structurally related compounds. The composition of secondary metabolites isolated from soft corals is dominated
by a diverse suite of bioactive diterpenes with over 50 unique scaffolds and >1500 unique diterpenoids isolated
to date. Many coral-derived diterpenes have potent and selective biological activity, including the xenicane,
acalycixeniolide F, which displays cytotoxicity against human leukemia cell line K562 (LC50 = 200 ng/mL) via an
undetermined mode of action. However, despite the promise these compounds exhibit as lead structures for the
development of novel medicines, the pharmaceutical potential of coral diterpenes remains untapped as neither
total synthesis nor isolation from aquaculture have provided sufficient material to enable effective in vivo clinical
testing. Through bioinformatic analysis of published soft coral genomes and transcriptomes, our group has
recently identified a series of terpene synthases that synthesize the hydrocarbon backbones of multiple coral-
specific diterpenes, including xeniaphyllene, the precursor to the archetypal coral diterpenes, the xenicanes.
Here, I propose to use the biosynthesis of the xenicanes as model for the development of a sustainable platform
for the microbial production of bioactive coral diterpenes.
This proposal aims to optimize the production of xenicane diterpenes through characterization and
directed evolution of enzymes involved in the synthesis and oxidation of the xenicane scaffold, culminating in
the reconstitution of xenicane biosynthesis through pathway engineering in methylotrophic yeast, Pichia pastoris.
Terpene synthases are often the rate-limiting step in terpenoid biosynthesis due to their low catalytic efficiency
and instability. In Aim 1, I will use a high-throughput, colorimetric substrate competition assay to screen error-
prone PCR-generated xeniaphyllene terpene synthase variants for improved activity and stability. To access the
core scaffold common to all xenicanes, the fused cyclobutane ring in xeniaphyllene must undergo an oxidative
carbon-carbon bond cleavage. In the recently published chromosomal level genome assembly of a Xenia sp.,
we found a suite of cytochromes P450 co-localized with the xeniaphyllene synthase. In Aim 2, I will explore the
oxidative chemistry of these cytochromes P450 in search of the unprecedented carbon–carbon lyase. Finally,
the reconstitution of xenicane biosynthesis will be explored in Aim 3, wherein I will use Universal Loop Assembly
(uLoop) to efficiently design and construct a refactored biosynthetic pathway for fermentative production of
xenicanes in P. pastoris. This research will provide invaluable insights into the enzymology behind the
construction of the biologically active xenicane coral diterpenes. Furthermore, the methods developed from this
work will facilitate the reconstitution of additional marine metazoan biosynthetic pathways, resolving supply
issues for further biological evaluation of these NPs.

Public health relevance
Project Narrative The xenicanes are a diverse family of anticancer diterpenes from soft corals with complex, heavily oxidized scaffolds that are unique to marine eukaryotes. In this proposal, I describe my strategy to engineer the terpene synthase that assembles xeniaphyllene (the hydrocarbon core common to all xenicanes), identify and characterize the oxidase(s) that generate the characteristic xenicane scaffold by catalyzing an unprecedented carbon–carbon bond cleavage, and assemble these enzymes into a refactored biosynthetic pathway for microbial production of xenicanes. Through this work we will gain key insights into the enzymology of terpenoid biosynthesis and enable the scalable and sustainable production of coral diterpenoids, facilitating the discovery and development of pharmaceutically relevant marine natural products.